Examining the long-term relationship between sleep and diet

PROJECT SUMMARY/ABSTRACT
Poor diet quality contributes to the excess burden of cardiometabolic diseases among U.S. adults. Short sleep
and poor quality sleep are increasing and have been linked to obesity and cardiometabolic diseases. There is
evidence that both diet and reduced sleep duration and quality impact African Americans and those with low
socio-economic status more so than other groups, and that these differences may contribute to health
disparities in cardiometabolic diseases. Specific aspects of diet have been linked to sleep outcomes in the
short term and similarly, experimental studies of sleep restriction have found short sleep can lead to poor
dietary choices and weight gain, demonstrating the bi-directionality of the diet and sleep relationship in the
near term. However, the inter-relationship between diet and sleep is complex and has rarely been studied in
the long-term nor with aspects of sleep beyond duration including quality, regularity, disturbance, and
sleepiness. Therefor, this study will address this knowledge gap by examining the long-term relationships
between diet and sleep in the Bogalusa Heart Study cohort of 1250 men and women from a biracial community
in Louisiana that have been prospectively followed for over 40 years, since childhood. The first aim of the
research is to prospectively examine the effect of multiple aspects of sleep (e.g. duration, quality, sleepiness)
on dietary intake in midlife among the Bogalusa Heart Study cohort. The second aim of the research is to
prospectively examine the effect of dietary intake in young adulthood on long-term sleep outcomes later in life
including sleep duration, quality, regularity, disturbance, and sleepiness accounting for body mass index, risk
for sleep disordered breathing, and physical activity. The third aim is to determine if differences by race,
biologic sex, and socioeconomic status exist in the relationships between diet and sleep over the life course.
The long-term goal in pursuing this research project and training plan is to produce an independent investigator
in nutritional and lifestyle epidemiology, well prepared to pursue a research career that alleviates the burden of
disparity in obesity and obesity-related morbidity and mortality for people in the Gulf South Region of the
United States. This will be achieved by meeting the overall objective of this project, implementing a tailored,
individualized, mentored research training experience that contributes to closing a long-standing knowledge
gap in the long-term relationship between diet and sleep. The impact of this work will be to produce a future
leader in nutritional and lifestyle epidemiology. The knowledge gained will allow for the development of
appropriately timed and targeted intervention opportunities to maintain healthy weight and sleep patterns that
prevent chronic cardiometabolic diseases among diverse populations in the U.S. while reducing health
disparities. The Bogalusa Heart Study cohort is a unique and ideal setting in which to perform this research.

Public health relevance
PROJECT NARRATIVE The proposed research will address the knowledge gap in understanding the long-term relationships between diet and sleep and determining the contribution of these relationships to health disparities in cardiometabolic diseases. This research could lead to more effective, tailored strategies to prevent obesity, cardiometabolic diseases, and improve health disparities. In addition, this program of mentored research and training will produce a researcher that is able to continue addressing similar important research questions as an independent investigator.